Early identification and prevention of acute compartment syndrome using a novel electrical impedance-based muscle-monitoring device

Project Summary
Acute compartment syndrome (ACS) remains one of the most devastating and readily overlooked
traumatic musculoskeletal disorders in clinical practice. In this condition, pressure increases in one of the body’s
space-limited compartments, due to direct trauma or bone fracture, resulting in injury to all of the compartment’s
contents, including muscle and nerve. Once full-blown ACS develops, the consequences are uniformly
catastrophic, with permanent tissue destruction, sometimes necessitating amputation. If caught early,
procedures can be used to save the limb. A non-invasive technology that can monitor for the development of the
condition both in and out of the hospital and even with the patient’s having a cast in place could serve a critical
purpose for ACS prevention. One approach that holds substantial potential for this purpose is electrical
impedance myography (EIM). In EIM, a weak electrical current is applied to a muscle or group of muscle and
the consequent surface voltages measured, providing an index of myofiber health. Previous studies of
impedance techniques have demonstrated high sensitivity to tissue ischemia and injury, including intracellular
edema and reductions in extracellular space. Thus, we hypothesize that the application of EIM to muscle could
serve as a sensitive method for assessing the onset of ACS. Myolex Inc, a Boston-based small business, has
as its main interest the design and development of EIM technology for broad medical use. The company in
conjunction with Beth Israel Deaconess Medical Center has studied the specific application of EIM technology
for the assessment of ACS in a well-established rat model of this disorder. Data collected and analyses
completed previously have demonstrated the sensitivity of EIM to the development of ACS. In this Phase 2
SBIR, we plan to extend the success of our early investigations by developing a self-contained,
wireless, battery-powered, wearable ACS detector that can even work on a casted limb that we have
called the Myolex® mAlertTM. In Specific Aim 1, building upon an already functioning early prototype, we will
create a system, that can be placed on a person at risk for ACS to assess the development of the condition.
The system will be wireless and small such that it can be applied prior to cast placement and be easily
removable once the period of concern has passed. We will test basic functionality in a small group of healthy
subjects. In Specific Aim 2, we will apply this system in a porcine model of ACS while simultaneously
measuring tissue perfusion pressures and also preforming measurement on the contralateral limb. We
anticipate showing the mAlert’s sensitivity to progressing muscle injury and to its improvement after fasciotomy.
At the conclusion of this work, Myolex will be well-positioned to test the device in human subjects at risk for
developing ACS and achieve ultimate FDA approval.

Public health relevance
Project Narrative Acute compartment syndrome (ACS) remains one of the most devastating and readily overlooked traumatic orthopedic disorders in clinical practice that can result in catastrophic injury, including loss of a limb. In this Phase 2 SBIR, Myolex, Inc, a small business concern based in Boston, MA, seeks to develop a small, convenient system based on established electrical impedance myography technology to serve as a monitor to detect the early development of ACS, called the mAlertTM. The developed system will then be tested in a large animal model of ACS for further refinement and to determine its accuracy. Success in this work will lead directly to applications in human ACS and, if successful, eventual FDA clearance.